Opening small packages: unraveling roles for microproteins during early vertebrate development

Project Summary
Human development relies on highly coordinated cell division, signaling, migration, and differentiation.
Any perturbations of the protein effectors that orchestrate these critical processes can lead to human birth defects
and/or diseases1-3. While our classical catalog contains around 20,000 proteins, evidence from ‘omics-based
techniques has generated a rapid paradigm shift in RNA biology4-12. Notably, RNA sequences defined as non-
coding in fact produce short proteins (£ 100 amino acids) called microproteins that modulate diverse processes13-
40 including heart function26, immunity22,27,41, and cell growth29,30. For example, a microprotein called APELA
maintains pluripotency in human embryonic stem cells20 and is critical for zebrafish heart development16,19.
However, additional microprotein function(s) during vertebrate development remain largely unknown.
Zebrafish is an outstanding model for interrogating vertebrate gene function. Their genetic tractability
coupled with external, synchronous development is well-suited for developmental analyses. Further, hundreds
of microproteins have been identified across zebrafish development using ribosome profiling, mass-
spectrometry, and conservation analyses16,42. Remarkably, APELA is the only microprotein out of these 400 that
is currently characterized. A key barrier to further microprotein investigation is that a majority of messenger RNAs
(mRNA) during early development are maternally provided and can mask the effects of a targeted gene
disruption. Our novel CRISPR/Cas13d system43,44 overcomes this barrier because it actively degrades its target
mRNA and therefore enables selective knockdown of maternally provided mRNAs in zebrafish. My preliminary
experiments with CRISPR/Cas13d have revealed that knockdown of one microprotein mRNA inhibits zygotic
genome activation and disrupts posterior patterning.
This study will combine CRISPR/Cas13d and ‘omics-based techniques to interrogate microprotein
function during zebrafish development. Aim 1 will leverage CRISPR/Cas13d to elucidate microproteins important
for early development. Then, Aim 2 will determine the cell and molecular processes that rely on developmental
microproteins. Together, these aims will define and characterize a population of microproteins involved in
vertebrate development. Experimental approaches will develop my skills in bioinformatics, molecular genetics,
developmental biology, and protein biochemistry. Microproteins critical for zebrafish development will be
informative for expanding the catalog of human proteins through comparative analyses. Further, microproteins
with functions during development represent uncharted therapeutic and/or diagnostic opportunities for human
birth defects and/or human diseases with developmental origins.

Public health relevance
Project Narrative Humans begin as fertilized eggs that coordinate the transformation into our familiar forms with biomolecules called proteins. Malfunctioning proteins can consequently result in birth defects, and emerging data has revealed many novel small proteins with the potential to affect human development. This study will discover the roles of these small proteins in development using an innovative system that targets and destroys protein making templates in the developmentally informative model zebrafish towards a better understanding of the players that cause human birth defects and diseases with developmental origins.